Supplement

Project summary:
(Original summary of the funded parent project R35 GM146862: Molecular Mechanism of Translation
Regulation by the eEF2K pathway)
This research project aims to provide a mechanistic and structural model of general and location-
dependent eukaryotic elongation factor 2 kinase (eEF2K) regulation and its downstream effects on the ribosome.
eEF2K is at the confluence of multiple upstream pathways whose signals it integrates. eEF2K’s only known
target is the eukaryotic elongation factor 2 (eEF2), which it phosphorylates on a single site. This eEF2K/eEF2-
axis is the predominant regulator of translation elongation and has a general role in cell homeostasis. It is also
an essential cue-dependent regulator of protein synthesis in localized regions of specific cell types, for example,
after neurotransmitter exposure in the synapses of neurons. eEF2 promotes the translation of specific mRNAs
while generally inhibiting translation. The mechanism of this paradoxical phenomenon is entirely unknown. We
recently showed that active eEF2K imposes a general translation shutdown in which phosphorylated eEF2 and
the phase-separating protein SERBP1 stably bind to ribosomes and renders them idle. This assembly suggests
possible mechanisms of eEF2-phosphorylation with respect to ribosome stability, mRNA decay, and ribosome
localization that collectively explain how eEF2-phosphorylation might lead to preferential translation of certain
mRNAs. eEF2K is associated with numerous human diseases, including neurological dysfunctions, infectious
diseases, cancers, and autoimmune disorders. Therapeutics targeting eEF2K are under development but
currently lack insufficient specificity. Thus, a mechanistic understanding of eEF2K-regulation and its downstream
effects are needed.
Under this award, we will pursue two key directions: 1) determine how eEF2K structurally integrates
signals from upstream pathways and affects its downstream regulation of eEF2, and 2) determine how
phosphorylated eEF2 and idle ribosomes regulate mRNA translation globally and locally. Here, we will test the
novel hypotheses that eEF2-phosphorylation regulates ribosome stability, mRNA stability, and ribosome
localization, which collectively confers the preferential translation of a specific mRNA subset. We will use an
integrated structural biology approach using single-particle and in situ cryogenic electron microscopy, paired with
biophysical, biochemical, and cell biology approaches to address these general and location-specific roles of the
eukaryotic elongation factor 2 kinase (eEF2K) pathway. Our proposed research program will open the door to
promising therapeutic approaches for the long list of eEF2K-related human diseases and, more broadly, expand
our understanding of translation elongation.

Public health relevance
Project Narrative: (Original project narrative of the funded parent project R35 GM146862: Molecular Mechanism of Translation Regulation by the eEF2K pathway) Many diseases are caused by inadequate protein synthesis at the right time and in the right place including major neurological disorders, cancers, cardiovascular disease, and autoimmune diseases. Understanding how this processes works is essential to understanding human disease and developing therapeutics. Therefore, this project aims to develop a molecular picture of the function and mechanisms by which a central regulatory hub, the elongation factor 2 kinase pathway, regulates protein synthesis.